EFFECTS OF SULFURIC ACID AEROSOLS ON PULMONARY DEFENSE MECHANISM

This study aims to evaluate pulmonary function, alveolar macrophage and lymphocyte populations and characteristics, and properties of airway mucus, in response to sulfuric acid aerosol exposure.